Shared Resource Management

PROJECT SUMMARY/ABSTRACT – SHARED RESOURCES MANAGEMENT (SRM)
The overarching scientific goal of Shared Resources Management is to enhance and accelerate UCCCC
members’ research by offering specialized expertise in cutting-edge technologies within our Shared Resources
Cores. The Shared Resources are crucial to the mission of the UCCCC and offer high-quality customized
services on state-of-the-art equipment, which aligns with the research conducted in our CCSG programs and
the pillars outlined in the UCCCC strategic plan. Shared Resource Management ensures the cores are managed
efficiently, so members have priority access to the shared resources at cost-effective and competitive rates.
There are currently 10 UCCCC cores, including Bioinformatics, Biostatistics, Cellular and Tissue-Based
Processing (cGMP), Human Immunological Monitoring Facility (HIM), Cytometry and Antibody Technology
Facility (CAT), Genomics Facility, Human Tissue Resource Center (HTRC), Integrated Microscopy (IM),
Integrated Small Animal Imaging Research Resource (iSAlRR), and Transgenic Mouse Facility (TMF). To meet
the UCCCC members’ needs and foster members’ scientific innovation and collaboration, the Shared Resources
are overseen and managed cooperatively between UCCCC and the Biological Science Division (BSD) Office of
Shared Research Facilities (OSRF). These cores are governed by the UCCCC Shared Resource Executive
Committee (SREC), which includes UCCCC and BSD leadership. SREC meets regularly to review members’
scientific needs, survey data, and metrics including budgets, usages, services, progress of developing cores,
allocations of philanthropic funds, and approval of core directors and Faculty Oversight Committee (FOC)
appointments. UCCCC members make up the majority of the membership on each of these oversight committees
to assure UCCCC needs are addressed. This cooperative management approach provides benefits to cancer
center members beyond what the Shared Resources cores provide alone, through cores such as Proteomics
and Cellular Screening Cores, which also support cancer-specific research studies. Currently, there are two
cores in development, the Organoid and Primary Cell Culture Research Core (OPCCR) and Cancer
Metabolomics, both of which were created to meet UCCCC members’ emerging research needs. In summary,
UCCCC Shared Resources have benefited greatly from CCSG support and this support has been leveraged to
provide added value to all UCCCC scientific programs. Shared Resources plays a crucial role in the research
mission and the strategic goals of the UCCCC and this continued support is critical to continuing to provide high
quality scientific services to UCCCC members at a reasonable cost and supports the discovery and development
of new Cores and services which support the UCCCC mission.